Thiol redox signaling in aortic aneurysm

PROJECT SUMMARY/ABSTRACT
Marfan syndrome is a connective tissue disorder caused by fibrillin-1 gene mutations, which predisposes to
thoracic aortic aneurysm and aortic dissection (TAAD). Aortic aneurysm in MFS usually remains clinically silent,
whilst progressively worsening until the aortic wall eventually dissects. Aortic dissections in MFS can occur even
at aortic dimensions not considered eligible for surgical repair, leading to sudden deaths. Molecular and genetic
culprits of TAAD are only partially understood, hampering the discovery of urgently needed therapies. Recent
evidence indicates increased oxidants in aneurysmal aortas of patients and animal models of MFS; however,
underlying redox mechanisms that may causally contribute to TAAD pathogenesis remain elusive. We found that
oxidants-induced post-translational modifications of cysteine thiols, specifically glutathionylation, are significantly
increased in aortas of individuals and a mouse model with Marfan syndrome (Fbn1mgR/mgR mice), and that sirtuin-
1 (Sirt1) is one of these glutathionylated proteins. Sirt1 is a NAD+-dependent lysine deacetylase essential to
suppress inflammation, matrix metalloproteinases (MMP2/9) activation and vascular smooth muscle cell (VSMC)
senescence. We hypothesize that oxidative inactivation of Sirt1 in VSMC is a redox mechanism contributing to
TAAD pathogenesis in Marfan syndrome. Specifically, loss of Sirt1 activity in VSMC due to glutathionylation
contributes to vascular media degeneration and aortic wall pathological remodeling by increasing VSMC
phenotyping changes, inflammation and MMP2/9 hyperactivation leading to aortic wall mechanical failure and
TAAD. We will study these aspects with two Specific Aims. In Aim 1, we will use Fbn1mgR/mgR mice in which Sirt1
is overexpressed and the de-glutathionylation enzyme glutaredoxin-1 (Glrx) is deleted, specifically in VSMC, to
examine cause-and-effect between Sirt1 glutathionylation and TAAD development. We will also use novel
genetic tools (adeno-associated viruses expressing a redox-resistant Sirt1 mutant or Glrx) to determine whether
preventing Sirt1 glutathionylation ameliorates TAAD in Fbn1mgR/mgR mice by suppressing VSMC phenotypic
changes and MMP2/9 activation. In Aim 2, we will use in vitro systems (human and mouse Marfan VSMC) to
elucidate whether lack of Sirt1 activity in glutathionylated Sirt1 contributes to VSMC phenotypic changes and
MMP2/9 hyperactivation via HMGA1, a newly identified Sirt1 deacetylation target. Overall, our innovative studies
will fill knowledge gaps on redox mechanisms of TAAD and pave the way for targeted therapies to prevent TAAD
in individuals at risk, such as those with Marfan syndrome, for which currently there are very limited treatment
options.

Public health relevance
PROJECT NARRATIVE Aortic aneurysms are abnormal dilatations of the aorta, the largest artery in the body, which often remain clinically silent until the aortic wall dissects, potentially leading to death. Despite tremendous advances in our understanding of genetic and molecular culprits behind these aortopathies, targeted therapies are still critically lacking. Our studies will examine whether oxidative post-translational modifications on the enzyme sirtuin-1 are associated with aortic wall degradation processes causing aortic aneurysm and will test whether preventing sirtuin-1 oxidation prevents these redox signaling processes thereby preventing aortic aneurysms and dissections.